Multimodal AI for aortic disease

Project Summary/Abstract
The aorta is central to cardiovascular health, with its structure and function significantly influencing disease risk
and organ damage. Aging leads to structural changes such as elastin degradation, fiber rupture, collagen
deposition, and calcification, resulting in adverse hemodynamic effects, including increased cardiac workload
and microvascular damage. While aortic stiffening has been extensively studied, the effects of age-related
changes in aortic geometry on cardiovascular health are less understood. Advances in artificial intelligence,
particularly convolutional neural networks, have enabled automated quantification of aortic structures,
uncovering prognostic phenotypes and genetic loci associated with aortic structure. These initial findings suggest
that aortic structure has significant predictive value for incident cardiovascular events, and that aortic structure
is influenced by genetic factors; however, time-varying remodeling patterns of aortic geometry, and their
relationship towards cardiovascular disease and genetics are unknown. Generative multimodal modeling offers
a solution by learning the underlying data distribution and creating task-agnostic, low-dimensional
representations that can be leveraged for multiple downstream tasks. This research will address key gaps in our
understanding of aortic structure by developing generative and multimodal AI methods to simulate age- and
disease-associated remodeling and creating an organ-specific and genetically-informed foundation models. Aim
1 seeks to develop a novel generative method to simulate three-dimensional aortic remodeling patterns. Using
imaging, clinical, and genetic data from the UK Biobank, a novel variational autoencoder (VAE) will be designed
to integrate imaging and clinical-genetic features. Aortic remodeling patterns will be generated by varying clinical
input variables and analyzing point-cloud shape variations. Through these simulations, novel phenotypes will be
identified based on 3D mesh variations. Novel phenotypes will be validated using time-to-event analyses. Aim 2
focuses on constructing a foundation model to improve diagnostic and prognostic tools for aortic and
cardiovascular diseases. Using multimodal contrastive learning, this model will integrate over 1,000,000 CT
scans, paired radiology reports, and genomic data from the Penn Medicine Biobank to align imaging features
with organ-specific measurements and genetic information. Segmentation and phenotype extraction protocols
will be employed to compute organ-specific features. Genetic information will be incorporated using 100+
polygenic scores. The foundation model will support advanced classification tasks, predicting incident
cardiovascular events with improved precision and generalizability compared to task-specific models. Together,
these efforts will enhance understanding of aortic remodeling processes, inform mechanisms underlying disease
progression, and provide innovative tools for cardiovascular risk assessment and intervention.

Public health relevance
Project Narrative The aorta undergoes complex structural remodeling with aging and disease, driven by genetic and environmental factors, which plays a critical role in cardiovascular health. However, current approaches provide limited insights into the progression of these changes and their implications for disease risk. The proposed research leverages generative modeling and multimodal learning to simulate age- and disease-associated aortic remodeling while developing an organ-specific, genetically-informed foundation model that integrates imaging, text, and genetic data for advanced diagnostic and prognostic applications in cardiovascular disease.